VitaminA and Sickle Cell Disease:Improving Suboptimal Status with Supplementation

DESCRIPTION (provided by applicant): Kelly Dougherty, Ph.D., is an Assistant Professor of Pediatrics at University of Pennsylvania (UPenn) Perelman School of Medicine and The Children's Hospital of Philadelphia (CHOP). Dr. Dougherty proposes a comprehensive, interdisciplinary training program that will provide her with the skills and experience necessary to develop into an independent academic patient-oriented investigator in pediatric research, focusing on clinical trials addressing nutrition- and physical activity-related issues affecting children with sickle cell disease (SCD). Her career development will be guided by an accomplished team of investigators in nutrition, growth, chronic disease, stable isotope assessment, ophthalmology, epidemiology / study design and biostatistics. Her primary mentor, Virginia Stallings, M.D. has conducted pediatric clinical nutrition and chronic disease research for the last 27 years and as Director of the Office of Faculty Development at CHOP, has an superb reputation for supporting the development of junior faculty into independent, NIH-funded, clinical investigators. The proposed mentored experience will take place in one of the most outstanding nutrition and SCD clinical research environments in the country. Dr. Dougherty's training will include advanced formal coursework in research design, biostatistics, research ethics and stable isotopes. This training is crucial to build upon the foundations of nutrition and SCD research knowledge that she obtained during her postdoctoral fellowship and UPenn Masters in Translational Research (MTR) thesis work and to prepare her for future R01 submissions to conduct nutrition intervention studies in children with SCD. The proposed research project will focus on suboptimal vitamin A (vit A) status which is prevalent in children with type SS sickle cell disease (SCD-SS) and associated with hospitalizations and poor growth and hematological status. The preliminary data in children with SCD-SS show that vit A supplementation at the dose recommended for healthy children failed to improve vit A status, resulting in no change in hospitalizations, growth or dark adaptation. This indicates an increased vit A requirement most likely due to chronic inflammation, low vit A intake and possible stool or urine loss. The dose of vit A needed to optimize vit A status in subjects with SCD-SS is unknown. The proposed research study will establish the safety and efficacy of vit A supplementation doses (3000 and 5000 IU/d) compared to placebo over 3 months in 66 children with SCD-SS, age 9-to 18-yrs and test the impact of vit A supplementation on the key functional and clinical outcomes. The key safety measures are concurrently elevated serum retinol (age specific) and liver function tests (3x age specific). Efficacy is evaluated by repletion of liver vt A stores using state of the art stable isotope methods. In SCD-SS, total body vit A pool size and liver vit A concentration are assessed before and after the 3 month intervention using the deuterated-retinol-dilution technique. Baseline vit A status will be assessed in similar healthy subjects as a comparison group. Vit A therapy has great promise to safely and economically improve complications and quality of life for patients with SCD. Well-designed trials are urgently needed to determine the clinical impact of vit A supplementation and this study is the next step.

Public health relevance
Project Narrative Optimal vitamin A (vit A) concentration and metabolism are essential for normal immune function, growth, development, reproduction, muscle function and vision in children, adolescents and adults with type SS sickle cell disease (SCD-SS). The impact of vit A supplementation will be evaluated for safety and efficacy using clinically important outcomes, and this will overcome the critical barrier for use of vit A supplementation in research and clinical care. Inexpensive and easy to administer, vit A supplementation may prove to be an effective and feasible treatment for symptoms and prevention of side effects for people of all ages living with SCD-SS in the US and around the world. __SpecificAimsTextDelimiter__ 10. Specific Aims Vit A is an essential nutrient in humans required for immune function, growth, development, reproduction, and vision1. The adverse health effects of vit A deficiency (serum retinol concentration <20 μg/dL) are numerous, including an increased risk of morbidity and mortality, reduced resistance to infection, impaired cellular differentiation, and higher rates of anemia, xerophthalmia (dry eyes), and dark adaptation/blindness2. We demonstrated that in US children with SCD-SS, suboptimal vit A status (serum retinol concentration <30 μg/dL) is prevalent and associated with increased hospitalizations and poor growth and hematological status3. Our preliminary data (see section below) suggest that compared to placebo, 12 months of vit A supplementation at the recommended dose for healthy children (Recommended Daily Allowance [RDA] for age and gender, Institute of Medicine [IOM]4) did not improve vit A status in 66 children with SCD-SS, ages 2.0 to 12.0 years, demonstrating that higher doses are needed5. At that time, the best measures of vit A status were assessed, including serum retinol, pre-albumin, retinol binding protein, and the relative dose response test. However, serum retinol concentration is not the optimal vit A status indicator to measure response to an intervention since it is homeostatically controlled and does not reflect liver vit A stores until liver reserves are dangerously low. Liver vit A concentration is the best indicator of vit A status since it is the primary tissue storage site, however liver biopsy tissue is rarely available from clinical indications. The older relative dose response test is based on the principle that when liver stores of retinol are high, serum retinol concentration is not changed by an oral dose of vit A, however when reserves are low, the serum retinol concentration increases markedly, reaching a peak 5 hours after the oral dose. Although the relative dose response gives an indication of vit A liver reserves (higher the response, the lower the vit A liver stores), it does not provide a sufficient quantitative estimate of total body vit A. Also it cannot be used to classify individuals across the full range of vit A status. Currently, the stable isotope dilution approach has emerged as the non-invasive gold standard measure of vit A status and is the only indirect technique that provides a quantitative assessment of total body vit A status across the continuum of status, from deficient to excessive vit A pool sizes. This technique has been validated against liver tissue vit A concentrations in adult surgical patients with low to adequate liver vit A concentrations6, 7. There are no known risks associated with the stable isotope (deuterium) labeled vit A used in this study. Using established assumptions of liver to body weight ratio, the liver concentration of vit A can be estimated. This technique has been successfully used to assess total body vit A pool size in children and/or adults in the United States8, Bangladesh7, 9, Guatemala10, China11, 12, Philippines13, Peru14 and Nicaragua15 and to evaluate the efficacy of vit A interventions. However, this state of the art methodology has not been used to measure total body vit A status and liver vit A concentrations in people with SCD-SS. In our pilot study, at screening 73% of children with SCD-SS had supoptimal vit A status, with a surprising 23% vit A deficient, a level that includes depletion of liver stores2. Thus, suboptimal vit A status is prevalent in children with SCD-SS and the dose needed to replete liver stores in this population is unknown. Therefore, using the innovative deuterated-retinol-dilution (DRD) technique (stable isotope) the research question addressed in the present study is: "what daily supplemental vit A dose is needed to obtain an adequate liver vit A concentration of at least 0.07 μmol/g liver (20μg/g liver)16-18?" This liver vit A concentration meets all physiological needs for the vitamin and supports an ongoing liver reserve to cover intermittent periods of low vit A intakes or periods of increased need such as SCD-related infection and pain events or other stressors that are common in SCD-SS19. The specific aims of this study are: Aim 1. To test two oral daily doses (3000 vs. 5000 IU) of vit A compared to placebo over a 3-month period in children with SCD-SS ages 9- to 18-yrs (n=66) to assess safety as determined by serum retinol concentration and liver function and efficacy to replete liver vit A stores as determined by achieving a minimum liver vit A concentration of 0.07 μmol/g liver (20μg/g liver) as assessed by the DRD technique. H1: Both vit A doses are safe as indicated by the low incidence (<5%) of the adverse event of elevated serum retinol (above age-specific range) associated with elevated liver function tests (>3x age specific range). H2: Daily vit A supplementation for 3 months results in liver vit A stores e0.07 μmol/g liver (20μg/g liver) in >80% of subjects. Aim 2. To assess vitamin A status in healthy African American children ages 9- to 18-yrs (n=22) to compare to subjects with SCD-SS. H1: Total body vit A pool size and liver vit A concentration will be significantly attenuated in children with SCD- SS compared to healthy children. Aim 3. To explore the impact of vit A supplementation on the key functional and clinical outcomes related to vision, immunity and muscle function in children with SCD-SS to support design of the future full scale trial.